A multimodal examination of Alzheimer's disease pathology and synaptic loss

PROJECT SUMMARY/ABSTRACT
Alzheimer's disease (AD) is the leading cause of dementia affecting nearly 7 million Americans, and the number
of affected individuals is projected to rise as the nation ages. In addition to the defining features of amyloid and
tau pathology, synaptic loss associates with cognitive dysfunction in AD, with postmortem investigations
revealing substantial reductions in synaptic density among people with dementia, and studies suggesting this
process may be linked with tau pathology. However, the accrual of AD pathology and associated synaptic loss
has been difficult to measure in living humans across the AD clinical and biological continuum. Thus, this F31
proposal aims to address this gap using in vivo measures of tau pathology secretion and neuroimaging of
synaptic density to better understand the biologic and clinical progression of AD. My proposed aims are to 1)
determine the extent to which tau pathology secretion associates with synaptic loss among richly characterized
participants on the AD continuum using blood biomarkers of AD and synaptic positron emission tomography
(PET), and 2) determine the regional relationship between tangle pathology and synaptic density using tau PET
and synaptic PET. This project will leverage the resources of the NIA-funded Wisconsin Alzheimer’s Disease
Research Center. The sample will include cognitively unimpaired AD biomarker negative and positive
participants, as well as individuals with mild cognitive impairment and participants with dementia due to AD. The
project leverages sophisticated and promising measures, including a novel plasma biomarker of brain-derived
tau pathology, hyperphosphorylated tau at amino acid residue 217 (pTau217) and [C-11]UCB-J, a PET
radioligand that binds to synaptic vesicle glycoprotein 2A (SV2A). This synaptic vesicle protein is found in
presynaptic nerve terminals throughout the brain and is a promising target for studying synaptic loss in individuals
across the AD continuum. The proposed study is expected to address gaps in knowledge about the progression
of AD and the factors that contribute to cognitive decline, and inform future intervention studies to mitigate
cognitive decline in AD. Finally, my mentorship team and I have developed a comprehensive and integrated
training plan for this fellowship which will support my research training as a committed predoctoral student from
a community which is underrepresented in the biomedical research workforce.

Public health relevance
PROJECT NARRATIVE Synaptic loss is strongly associated with cognitive dysfunction in Alzheimer’s disease (AD) and autopsy studies show that loss of synapses is closely linked with tau pathology; however, this has been difficult to measure in living people. The proposed project will examine the extent to which tau pathology is associated with synaptic loss using neuroimaging and blood biomarkers of AD, which will inform on the progression of AD and potential windows for treating this disease. This project will also support the training of a promising pre-doctoral student to address the nation's biomedical, behavioral, and clinical research needs in AD.